Cancer-specific dependencies within the NuRD chromatin remodeler complex: new targets and chemical tools

PROJECT SUMMARY/ABSTRACT
Histone deacetylases (HAT) are zinc-dependent enzymes that catalyze the removal of acetyl groups from the
epsilon amine of lysine side chains. These proteins have been widely pursued as anti-cancer drug targets, but
therapeutic development has been largely unsuccessful given the essential nature of many HDAC proteins.
Recently, we discovered a synthetic lethal relationship between HDAC1 and HDAC2, which is caused by
recurrent chromosomal deletions that result in hemizygous deletion of HDAC1 in neuroblastoma and HDAC2 in
multiple myeloma. As a result of HDAC1 deletion, neuroblastoma cells are hypersensitive to disruption of
HDAC2, and vice versa in multiple myeloma. Using dTAG-mediated degradation or CRISPR/Cas9-based gene
disruption, we discovered that targeting HDAC1/2 synthetic lethality (e.g. degrading HDAC2 in neuroblastoma
cells with a hemizygous HDAC1 deletion) results in dissociation of the NuRD chromatin remodeler complex, of
which HDAC1/2 are members. Dissociation of the complex results in degradation of NuRD subunits that are
selectively required for neuroblastoma and multiple myeloma survival, suggesting that HDAC1/2 synthetic
lethality can be leveraged to target subunit-specific NuRD vulnerabilities in cancer. We hypothesize that HDAC1
deletions cause the NuRD subunits, HDAC2 / MBD3 / MTA3, to be essential for neuroblastoma, whereas HDAC2
deletions cause vulnerabilities to loss of their paralogs, HDAC1 / MBD2 / MTA2, in multiple myeloma. Here, we
will address this hypothesis and explore the translational potential of these vulnerabilities by developing small-
molecule modulators that target NuRD structure and/or function. In Aim 1, we will (i) Determine whether MBD
and MTA vulnerabilities are caused by HDAC1/2 deletions using CRISPR/Cas9, inducible RNAi, and dTAG-
based approaches in vitro and in vivo, (ii) Reveal whether the loss of NuRD subunits required for cancer cell
survival leads to dissociation and/or degradation of the NuRD complex using unbiased proteomics approaches,
and (iii) Establish if HDAC1/MBD2/MTA2 and HDAC2/MBD3/MTA3 form distinct NuRD sub-complexes as a
result of HDAC2 and HDAC1 deletions, respectively. These experiments will determine if subunit-specific NuRD
vulnerabilities are caused by HDAC1/2 deletions or simply exploited by HDAC1/2 synthetic lethality. In Aim 2,
we will develop small molecules targeting the NuRD complex to exploit NuRD vulnerabilities in genetically
defined cancer sub-types. Specifically, we will: (i) develop paralog-selective PROTACs that distinguish between
HDAC1 and HDAC2, (ii) determine the potential for covalent ligands of MTA3-Cys532 to disrupt NuRD structure
and/or function in MTA3-dependent cancers, and (iii) develop MTA3-targeted PROTACs based on ligands that
covalently engage MTA3-C532. Altogether, successful completion of these aims will determine the mechanisms
underlying NuRD vulnerabilities in cancer and advance novel chemical tools to drug and study them.

Public health relevance
PROJECT NARRATIVE While clinical development of HDAC inhibitors for oncology has been largely unsuccessful, we recently discovered a synthetic lethal relationship between HDAC1 and HDAC2 that should offer a greater window for therapeutic development. Based on our preliminary data that members of the HDAC1/2-containing NuRD chromatin remodeler complex are required for the survival of cancers impacted by HDAC1/2 synthetic lethality, we propose to (i) determine the mechanistic basis underlying NuRD vulnerabilities in these cancers and (ii) develop small-molecule modulators of NuRD function that target cancer-specific NuRD vulnerabilities.